Development of a high precision and high order DNA counting platform

PROJECT SUMMARY/ABSTRACT
Enumerix has developed a cost-effective method to perform high order DNA counting at high precision
called direct count PCR (dcPCR). dcPCR uses a spin column method that generates millions of
partitions directly into PCR tubes for target amplification, using standard laboratory centrifuge and
thermal cyclers, followed by an ultra-rapid method to count up to 1 million copies of DNA directly from
the same PCR tube. We have demonstrated that our technology far exceeds the precision of digital
PCR, and can perform at a DNA counting range akin to quantitative PCR and next generation
sequencing, which makes it a suitable next-generation DNA counting platform. For this proposed Phase
II project we plan to further develop our dcPCR platform with the goal to distribute the technology to
end-users to replace quantitative PCR and digital PCR.

Public health relevance
PROJECT NARRATIVE Currently, quantitative PCR (qPCR) is one of the most abundant DNA quantification tools available and is widely used in molecular diagnostics, such as COVID-19 test. The drawback to qPCR is that the data is not digitized and requires more test controls in order to interpret the results. Enumerix aims to circumvent this limitation by developing the next generation DNA quantification tool called direct count PCR (dcPCR) where the DNA data is digitized and rivals the sensitivity and dynamic range of qPCR in a cost effective manner.